Engineering mRNA encapsulated extracellular vesicles for in vivo chimeric antigen receptor macrophage therapy for glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM) is the most common and lethal primary central nervous system cancer in adults, where
treatments are ineffective and often debilitating. Unlike many other peripheral solid tumors, GBM is highly
resistant to cancer immunotherapy. The absence of immune infiltrates in GBM results in an immunologically
“cold” tumor and intrinsic immune resistance mediated by GBM cells is an additional factor contributing to the
failure of immunotherapy in GBM thus far. Chimeric antigen receptor (CAR) T-cell therapy has recently shown
remarkable success in the treatment of hematologic cancers, and there have been attempts made to explore
CAR T cell strategies against GBM. However, CAR T cells for GBM face challenges including intratumor
heterogeneity, dynamic expression of target receptors, and often the inability of T cells to traffic to tumors to
mediate the desired antitumor effect. In contrast to the lack of T cell infiltrates, many solid tumors, especially
GBM, are abundant in immune suppressive myeloid cells including macrophages. Therefore, converting these
immune suppressive cells into tumoricidal phenotype represents a promising strategy for cell-based therapy.
There is now strong interest in generating CAR macrophages in which autologous macrophages are
transduced with CARs delivered by viral vectors ex vivo to enhance their effector functions. However, ex vivo
preparation of CAR macrophages is complex, time consuming, and due to the non-dividing nature of
macrophages, is often inefficient. We propose an innovative strategy that represents a revolutionary way to
produce CAR macrophages in vivo and offers a promising new approach for cell therapy against GBM. This
will be the first study to evaluate the feasibility of producing CAR macrophages in vivo using an mRNA delivery
platform and to assess the antitumor efficacy of CAR macrophages for GBM immunotherapy. We hypothesize
that generating CAR macrophages targeting the Epidermal Growth Factor Receptor Variant III (EGFRvIII) in
vivo using mRNA-loaded exosomes will have significant activity against GBM. EGFRvIII is a mutant protein
that is expressed on the surface of 50% of GBM cells. Our previous study showed that we can efficiently
produce mRNA-loaded exosomes to restore protein expression in solid tumors in vivo. Furthermore, our
preliminary experiments showed that the exosomes loaded with EGFRvIII CAR mRNA can produce CAR
macrophages in vivo with enhanced effector functions. Our current study will test the overall hypothesis
through the following specific aims. In Aim 1, we will evaluate the dynamics and toxicity of CAR macrophage
production in vivo using CAR mRNA exosomes. In Aim 2, we will evaluate transcriptomic and functional
profiles of in vivo generated CAR macrophages. Finally, in Aim 3, we will assess the antitumor effect of in vivo
generated CAR macrophages as a monotherapy or in combination with other myeloid-directed therapy against
both murine and human EGFRvIII expressing GBMs. If successful, our proposed research can overcome a
major technical hurdle that has limited cell therapy in GBM and greatly expand its utility for cancer treatment.

Public health relevance
PROJECT NARRATIVE Chimeric antigen receptor (CAR) macrophage therapy offers great promise against solid tumors including glioblastoma (GBM). Our current study proposes an innovative strategy to use exosomes-loaded with mRNA encoding a CAR that targets the epidermal growth factor receptor variant III (EGFRvIII), a mutant receptor expressed in 40% of GBM, to produce CAR macrophages in vivo for GBM immunotherapy. If successful, the results generated from the proposal will pave the way for a new strategy to produce CAR cells in vivo and greatly expand the utility of cell therapy against GBM.